The Columbia University Irving Medical Center (CUIMC) NHLBI Health Equity StARR Program

PROJECT SUMMARY / ABSTRACT
The Columbia University Irving Medical Center NHLBI Health Equity StARR Program will
identify, train, and provide longitudinal support to expand the next generation of diverse,
interdisciplinary physician scientists to advance outcomes and reduce disparities for patients
with heart, lung, blood, and sleep-related diseases across the lifespan. We recognize the
declining fraction of the scientific workforce represented by physician-scientists. We recognize
the particular dearth of women, under-represented minorities, and those from other traditionally
marginalized backgrounds, both in the physician-scientist pipeline and as mentors. We also
recognize that there is robust science that underlies our understanding of equity, disparities, and
the transformation of both. The goal of this program is to identify, train, and retain a next
generation of diverse physician scientists to advance science related to heart, lung, blood and
sleep diseases, with focus on working across disciplines to advance health equity. This will be
accomplished through the following Aims: 1) Identify promising, resident physicians across
Surgery, Cardiovascular Surgery, Pediatrics, and Internal Medicine, with a particular focus on
inclusion of women, under-represented minorities, and physicians scientists from other
traditionally disadvantaged and backgrounds; 2) Implement rigorous didactic and applied
learning with a focus on working across disciplines to advancing health equity; and 3) Pair these
resident scientists with interdisciplinary, diverse mentors, committed to rigorous research
methodology and mentorship, before, during, and at least 2 years beyond the CUIMC NHLBI
Health Equity StARR Program, to ensure retention of well-trained, diverse, and fulfilled
physician scientists. To support this training, we bring together not only three different clinical
departments focused on heart lung, blood and sleep diseases and Columbia University’s Center
for Clinical and Translational Science Award (CTSA; the Irving Institute), but also Columbia
University’s School of Medicine, School of Nursing, Mailman School of Public Health,and the
Columbia University Center for Research on People of Color. This Program will consist of three
tracks: 1) Health Services & Learning Health Systems, 2) Basic & Translational, and 3) Clinical
Science. Completion of these aims will recruit, train, and provide longitudinal support for
diverse, interdisciplinary resident investigators, prepared to apply for early career and career
development research awards and to embark on methodologically rigorous careers to advance
health equity.

Public health relevance
Project Narrative There is a critical need to expand the pool of diverse, clinician scientists who can combine personal and clinical perspectives with sophisticated research methodologies to advance health outcomes and reduce health disparities. The goal of the Columbia University Irving Medical Center (CUIMC) NHLBI Health Equity StARR Program is to identify, train, and retain a next generation of diverse physician scientists to advance health equity through health services, learning health systems, translational, basic science, and clinical research, focused on heart, lung, blood, and sleep diseases across the lifespan.